Defining the MAST4 interactome in brain development and epilepsy

PROJECT SUMMARY
Epilepsy is a common and costly cause of morbidity and mortality in children and adults. Developmental and
epileptic encephalopathies (DEEs) are severe childhood epilepsies that require rapid diagnosis to initiate
treatment that will control seizures and prevent or reverse the loss of neurologic function. However, these
seizures often do not respond to medications. Most DEE patients are expected to have a known underlying
genetic etiology, but they often lack a molecular diagnosis because the potential pathogenic variants are in
genes that have not yet been associated with neurological dysfunction. We have identified de novo variants in
the MAST4 gene in patients with developmental delay, DEE, vision abnormalities, and in some, structural brain
abnormalities. MAST4 is a member of an understudied family of serine threonine kinases (MAST1-4 and
MAST-like) that is among the IDG-eligible proteins with high potential to impact human health as a therapeutic
target for epilepsy. In Aim 1, we will characterize MAST4 spatiotemporal expression in neurodevelopment and
identify MAST4 interacting proteins in vivo using label-free mass spectrometry. In Aim 2, we will validate
MAST4 interacting proteins and the impact of patient-specific mutations on these interactions in primary
cultured neurons in vitro. The results from these experiments will provide both important functional data and
tools to instruct the path to precision medicine for DEE patients with MAST4 mutations.

Public health relevance
PROJECT NARRATIVE Developmental and epileptic encephalopathies are a variable group of severe childhood epilepsies that are suspected to be genetic, but causal genes are only beginning to emerge. MAST4 is a new DEE candidate gene and an IDG kinase with little known about its properties and functions. We will define the MAST4 interactome as a resource to investigate therapeutic targets for epilepsy.